Oncology Research Training Grant

Abstract
The Oncology Research Training Program (ORTP) has been in existence for 35 years and was developed with
the primary goal of preparing physician-trainees (fellows in Adult Medical Oncology) for careers in academic
medicine. The rationale for training in oncology research is four fold: (a) Cancer remains one of the leading cause
of morbidity and mortality; (b) there is a need to maintain momentum that has been achieved in our fundamental
understanding of carcinogenesis, genomics and immunology (c) there is a need to translate progress gained in
the laboratory to the development of novel and better strategies for the diagnosis, therapies and and prevention
of cance and (d) in the rapidly chaniging health care advances and economics landscape, a critical need for
development of tools and policy to determine the most effective and efficient ways to deliver care and measure
outcomes in the society. The five Research training themes of the Program are carefully developed to build on
the past successes of training academic leaders. It melds emerging aspects of cancer biology, care and policy,
is aligned with the investigative interest and expertise of 34 established, extramurally-funded program faculty
members, leverages the outstanding resources of the Division of Hematology/Oncology, the Comprehensive
Cancer Center (UMCCC), the medical school and other units of the University of Michigan. The research training
themes are: (1) Molecular-genetic mechanisms of neoplastic transformation, aberrant signaling, and metastasis,
(2) Biomarkers in cancer prevention and therapy; (3) Molecular targets of drug discovery and experimental
therapuetics of cancer; (4) Immunological approaches to cancer therapy and (5) Health services research
focused on delivery, outcomes, reform and value. The trainees selected for this program will first experience
well-defined curriculum and training to the important concepts in the chosen research theme, and then spend 2-
3 years in the relevant laboratory and/ or clinical or health services research environment under the direct
supervision of a training program faculty mentor. The trainees will develop skills in: (a) to identify important
questions in oncology research (b) develop testable hypotheses that will address the pertinent questions (c)
aquire the necessary technical expertise to rigorously test the hypotheses identified; (d) critically evaluate the
data generated; (e) develop the necessary skills of written and oral communication to promulgate the conclusions
made and (f) develop and compete of peer-reviewed grants. The trainees will have an MD or MD-PhD degree,
3 years of house officer training in Internal Medicine and a year of clinical subspecialty training in ADULT medical
oncology/hematology. The ultimate goal of the program is to prepare trainees for careers in academic oncology
as independent faculty members in schools of medicine at research universities.

Public health relevance
Narrative The goal of the Oncology Research Training Program is to teach MD cancer specialists-in-training the skills necessary to pursue careers in cancer research so that they can contribute to the development of advances in the prevention, diagnosis, and treatment of cancer.